Multiplex functional assay of variant effect in the retinal transcription factor CRX

PROJECT SUMMARY
The transcription factor Cone-Rod Homeobox (CRX ) is a master regulator of photoreceptor cell fate. Sequence
variants in CRX can cause Retinitis Pigmentosa, Cone-Rod Dystrophy, and Leber Congenital Amaurosis, all
inherited causes of vision loss and blindness. CRX is the only gene implicated in the pathogenesis of all three of
these diseases, which present with both rod- and cone-centric phenotypes of varying age of onset and severity.
Several CRX variants have been reported to cause severe dominant disease through antimorphic genetic interac-
tions with wild-type CRX, and yet these mutations are adjacent to variants which are benign or only cause mild,
recessive disease. Determining which mutations in CRX are pathogenic and quantifying their effect on functional
activity is prerequisite to interpreting patient variation and predicting patient phenotypes.
However, most variants in CRX are “Variants of Uncertain Signiﬁcance” (VUS), meaning that insufﬁcient clinical
or functional evidence exists to determine their pathogenicity. Without a robust catalog of human genetic
variation, advances in patient sequencing cannot be translated into clinical guidance or therapies for patients with
uncharacterized variants. One potential solution to this challenge is Deep Mutational Scanning (DMS), which
uses massive libraries of variant sequences in multiplexed assays to simultaneously measure the functional
consequence of thousands of variants in a gene of interest in a single experiment. In DMS, each gene variant is
assigned a quantitative functional pathogenicity score based on its activity in a molecular assay.
This proposal will use DMS to simultaneously assay the transcriptional activity and abundance of all point
substitutions, truncations, and frameshifts in CRX. The direct product of this work will be a “look-up table” listing
the functional consequence of every CRX variant on protein activity and stability, which will be directly applicable
to clinical variant classiﬁcation and decision making. Given the retina's privileged location as a facile target for
gene therapy, a catalog of human variation in CRX could inform the clinical management of patients afﬂicted with
inherited retinopathies in the near term. Furthermore, this work will establish an extensible platform for additional
DMS studies of other retinal transcription factors, broadly expanding our understanding of inherited retinal disease.

Public health relevance
PROJECT NARRATIVE Genetic variants in the gene CRX can cause inherited retinal diseases that lead to vision loss and blindness, but many CRX genetic variants are uncharacterized. This proposal aims to apply Deep Mutational Scanning, a new technique for studying many genetic variants at the same time, to comprehensively identify genetic variants in CRX that cause disease. This work will produce a “look-up table” listing all possible variants in CRX by their functional activity and propensity to cause disease, and will be directly applicable to the diagnosis of patients with diseases caused by mutations of CRX.